INFLUENCE OF AGE ON THE REGULATION OF NUTRIENT BALANCE IN HUMANS

The purpose of this study was to determine the influence of age on the ability to adjust nutrient oxidation to changes in diet composition. We studied 6 young (YM; age=25+1 yrs) and 5 older (OM; age=63+3 yrs) men after 4 days of consuming each of 3 isocaloric diets containing a constant %protein but varying in %carbohydrate and %fat (order randomized): mixed diet (M;15/30/55), high fat diet (HF;15/60/25), and high carbohydrate (HC; 15/15/70). Each subject underwent 24-hr whole-room calorimetry on day 4 of each diet to determine 24-hr nutrient oxidation rates. Body mass, %fat, and fat-free mass were similar in the two groups. 24-hr EE and energy balance did not differ across diets or between groups; 24-hr EE was ~7% lower (ns) in the OM. Nutrient oxidation was similar in Y vs. O during M. Protein oxidation was similar across diets, but higher (P<0.05) in OM. Fat oxidation increased to 58.4+14.9 vs. 51.9+13.0% of 24-hr EE (ns) in the OM vs. YM, respectively, during HF and decreased to 25.4+9.7 vs. 20.2+14.3% (ns) during HC (diet effect, P<0.05). Carbohydrate oxidation decreased to 19.5+10.6 vs 29.9+12.6% (ns) during HF and increased to 53.6+12.3 vs. 64.7+14.3% (ns) in the OM vs. YM, respectively during HC (diet effect, P<0.05). Taken together, these results suggest that OM maintain the ability to adjust nutrient oxidation to changes in diet composition.